Core 3: Biostatistics and Bioinformatics Core (BBC)

PROJECT SUMMARY/ABSTRACT – Biostatistics and Bioinformatics Core (BBC)
The overall goal of Core 3, the Biostatistics and Bioinformatics Core (BBC), is to provide comprehensive support
in the areas of biostatistics and bioinformatics for all research Projects, Developmental Research and Career
Enhancement programs, and Cores in the UCLA SPORE in Brain Cancer. The BBC is comprised of multiple
faculty members from the departments of Biostatistics, and Molecular, Cell, & Developmental Biology (MCDB),
as well as staff statisticians and bioinformaticians. Faculty members include nationally respected biostatisticians
and bioinformaticians with broad expertise in general biostatistics, design and analysis of clinical trials, analysis
and interpretation of high-dimensional tissue arrays and gene expression data, and next generation sequencing
(NGS) data analysis, which are needed by the SPORE research projects. Collectively and individually, the
members have participated in hundreds of studies involving diverse aspects of cancer research, especially
translational research. They have experience working in large centers and have served on multiple NIH study
sections and review committees. The BBC faculty and staff are actively involved in UCLA Jonsson
Comprehensive Cancer Center (JCCC)'s current projects and have an established a history of productive
collaborations with the researchers in this proposed SPORE. The BBC has worked closely with the UCLA
SPORE in Brain Cancer investigators to provide input on study design, statistical analysis plans, and
bioinformatics issues for this competitive renewal application.